3D Culture Models of Partial-EMT and Its Regulation in Oral Cavity Squamous Cell Carcinoma

PROJECT SUMMARY
Head and neck squamous cell carcinoma (HNSCC) is the sixth leading cause of cancer death. Current limitations
in our understanding of intratumoral cellular heterogeneity (ITH) in HNSCC cause major challenges in patient
stratification and development of novel targeted therapeutics. Our seminal single cell RNA-sequencing (scRNA-
seq) analysis of oral cavity squamous cell carcinoma (OSCC) revealed a partial epithelial-to-mesenchymal
transition (p-EMT) program that is a key feature of ITH in HNSCC. p-EMT is characterized by expression of a
unique set of mesenchymal markers, without loss of epithelial markers or expression of classical EMT
transcription factors and is associated with invasiveness and treatment failure. We demonstrated that
transforming growth factor beta-3 (TGF-β3) from cancer associated fibroblasts (CAF) drives p-EMT via cancer
cell TGFβ-induced (TGFBI), a principal marker of the unique subpopulation. As in vitro efficacy of TGFβ inhibitors
targeting EMT has not translated to the clinic, there is a clear need for better models of in vivo biology. Current
modeling of p-EMT is hindered by the inability of OSCC cell lines in monolayer culture to capture ITH or p-EMT.
In contrast, three-dimensional patient derived organoids (PDO) maintain differentiation gradients, recapitulating
cancer cell heterogeneity. We will use OSCC PDOs and CAFs to investigate the role of the novel TGF-β3-TGFBI
axis in driving p-EMT and the value of p-EMT as a predictive biomarker for response to therapy.
First, to determine the mechanism by which cancer cell TGFBI regulates p-EMT to promote tumor growth and
metastasis, we will use CRISPR interference (CRISPRi) to knock down TGFBI in OSCC PDOs and evaluate the
impact on p-EMT. To model the functional impact of this knockdown, we will orthotopically transplant TGFBI-
modulated PDOs into the buccal mucosa of immunodeficient mice, anticipating that TGFBI knockdown will
reduce p-EMT, tumor formation, and metastasis. Second, to determine the mechanism by which CAF influence
OSCC p-EMT via the TGF-β3-TGFBI axis, we will use CRISPRi to knock down TGF-β3 in OSCC CAFs and co-
culture modified CAFs with OSCC PDOs. To assess the impact of TGF-β3-TGFBI signaling on xenograft tumor
growth and metastasis, we will then orthotopically co-transplant modified CAFs and PDOs into NSG mice. Third,
to determine how p-EMT predicts therapeutic response, we will treat TGFBI-modified PDOs, with or without
admixed TGF-β3-modified CAFs, with a series of standard OSCC chemotherapies, as well as inhibitors of the
TGFβ pathway. To support the use of p-EMT as a predictive biomarker, we will then treat our large biobank of
OSCC PDOs with this same set of therapies and determine the relationship between p-EMT expression and
therapeutic response. We anticipate that p-EMT, induced by the TGF-β3-TGFBI axis, will be associated with
differential responses to standard and TGFβ-targeting therapies, supporting its use as a predictive biomarker.
Beyond OSCC, our study may provide the basis for a paradigm shift in therapies targeting p-EMT and other rare
subpopulations, as well as the paracrine interactions that drive them.

Public health relevance
PROJECT NARRATIVE Head and neck cancers are the sixth leading cause of cancer death worldwide, in part due to major challenges in patient stratification that have prevented the use of novel targeted therapeutics. The proposed work seeks to utilize three-dimensional (3D) culture models of oral cancers, the most common subsite of head and neck cancer, to better understanding of the biology associated with aggressive disease, as well as tumor features that may predict response to both standard and novel targeted treatments. We believe this approach is applicable beyond oral cancers, and the proposed work may support a paradigm shift toward using such 3D culture models to predict patient response to novel targeted therapies, particularly in the recurrent or metastatic setting.